Post-Hospital Intervention for Veterans with Comorbid Bipolar and Substance Use Disorders

Background: A growing number of Veterans are presenting to the Veterans Health Administration (VHA) for the
treatment of Bipolar disorder (BP) and co-occurring substance use disorders (SUDs), with prevalence of SUDs
in patients with BP up to 60%. This comorbidity is associated with increased symptom severity, poorer treatment
outcomes, and greater use of costly health services such as psychiatric hospitalization. Significance/Impact:
Veterans who transition from psychiatric hospitalization to outpatient care are at heightened risk for treatment
nonadherence, mood/substance relapse, deaths due to opioid overdose, and suicide. Nonadherence to
treatment is a significant problem among patients with BP, which is further magnified among those with SUDs.
Nonadherence leads to increased need for psychiatric readmission, with BP patients recently discharged from
inpatient care particularly likely to discontinue pharmacotherapy, relapse to substances, and attempt suicide. Of
particular concern are disproportionately greater rates of suicide in Veterans with BP relative to those with other
mental health conditions. Veterans with BP who use substances, particularly alcohol and opioids, have the
highest suicidality and mortality rates. To date, there is little research on effective and feasible behavioral
aftercare interventions designed to improve treatment adherence in this high-risk, comorbid population at the
critical period following hospital discharge. Innovation: Empirical work suggests that the “Integrated Treatment
Adherence Program” (ITAP) may be an ideal therapeutic approach to improve treatment adherence and clinical
outcomes in Veterans at the critical period of transition to outpatient care following hospitalization. ITAP is an
innovative psychosocial intervention developed by our team designed to improve treatment adherence and
reduce suicidality, bipolar symptoms, and substance abuse among high-risk patients, addressing HSR&D major
research priorities. ITAP combines in-person engagement sessions with follow-up phone contacts and significant
other involvement as an adjunct to treatment as usual over 6 months post-hospitalization. Methodology: The
proposed Hybrid Type 1 Effectiveness-Implementation Trial will evaluate the effectiveness of ITAP in a sample
of 140 Veterans with BP-SUD, randomized to receive either the ITAP intervention or a Safety Assessment and
Follow-up Evaluation (SAFE) comparison condition, both delivered as adjuncts to VHA treatment as usual.
Veterans will be recruited from the Providence VAMC inpatient psychiatric unit and assessed at baseline and at
3 (mid-treatment), 6 (post-treatment), and 9-month follow-up. The Primary Aim is to test the hypotheses that
participants randomized to receive ITAP, relative to SAFE, will evidence improved treatment outcomes at post-
treatment, maintained through follow-up. Primary outcomes are: 1) greater treatment adherence defined by (a)
percent missed medications doses/month (based on electronic monitoring) and (b) percent missed VHA mental
health appointments/month. Secondary outcomes are: (2) reduced suicidality and number of psychiatric
hospitalizations/ER visits; and (3) lower depressive and manic symptoms, lower percentage of alcohol and drug
use days, and improved overall psychosocial functioning. The Secondary Aims are to identify the mechanisms
of action targeted by ITAP, moderators of treatment effects, and perceptions of key stakeholders and contextual
factors that may reduce barriers and increase organizational readiness for implementation of ITAP in the VHA.
Next Steps/Implementation: If shown effective and in cooperation with our operational partners, the next steps
for ITAP would be to conduct a Hybrid Type 3 Implementation Trial to test specific implementation strategies
within a multi-site study and to develop an implementation blueprint for ITAP-based standard of care within the
VHA. Determining whether ITAP is an effective adjunctive treatment directly addresses the need for improved
adherence to evidence-based mental health and substance use treatments and the need for effective suicide
prevention interventions in Veterans. Should ITAP prove effective, we will work with our operational partners to
prioritize ITAP’s ultimate dissemination and implementation within VHA.

Public health relevance
Veterans with bipolar disorder (BP) and comorbid substance use disorders (SUDs) have poor treatment adherence and poor clinical outcomes, high rates of suicide, and increased psychiatric hospitalization. They are at particularly high risk for treatment nonadherence when transitioning from psychiatric hospitalization to outpatient care, with little to no treatment options available to improve care of this high-risk population at the critical period following hospital discharge. The current project will test the effectiveness of Integrated Treatment Adherence Program (ITAP), which is the first adjunctive psychosocial program specifically designed to improve treatment adherence and reduce suicidality, bipolar symptoms, and substance use among high-risk patients with BP-SUD. If shown effective, ITAP could be easily and efficiently adopted as standard care for hospitalized Veterans with co-occurring BP and SUD within VHA. Findings from this study will inform clinical and policy efforts on the implementation of BP treatment for Veterans with co-occurring SUD post-discharge.